Data Science Core

PROJECT SUMMARY - DATA SCIENCE CORE
Significance: Effective climate change actions are hampered by a lack of transdisciplinary and community-
informed data, fragmented health surveillance systems, and insufficient local and regional climate data.
Community engagement is pivotal for meaningful data collection and effective policy change, yet challenges
arise from the digital divide. An integrative data approach, and advanced data science methods, such as 'climate
computing', can address these complexities and lead to effective and sustainable climate–health policies and
ensure their adoption with community involvement. Innovation: Central to our Data Science Core (DSC) is a
groundbreaking initiative: the union of data science with deep, reciprocal community interaction. Our team aims
to embed community feedback into every facet of research, including data collection, synthesis, and
dissemination of results. Historically, community-focused research and bioinformatics have been distinct fields.
This initiative strives to bridge the gap by “bringing the power of data to all the stakeholders.” Our proposed
approach includes: 1) a revolutionary, crowdsourced, community-based data collection system, in which data is
relevant and actionable, 2) a holistic approach to data integration, combining diverse disciplines, 3) advanced
data analysis using Artificial Intelligence (AI) and Machine Learning (ML), and 4) effective communication of
results to all stakeholders, including community, academia, government, and public. Our team has extensive
experience in developing and applying analytical techniques and public interfaces that can enrich research
projects facilitated by the Center. Building upon prior work of community-engaged data science from national to
local scales, the proposed research activities will consist of three primary aims: 1) Community Integration with
Data which underscores the importance of embedding community feedback into our data foundations. The DSC
will develop state-of-the-art informatics tools to effectively engage communities, including, an AI-assisted tool
translating findings into digestible insights for the wider public, 2) Real-World Data Commons which revolves
around the creation of a prototype integrating community insights with multifaceted data on climate, policy, and
health. It will also serve as a public resource, providing scripts, datasets, and visualization tools that ensures
community voices are central, through collaboration with the Community Engagement Core, and 3) Analytical
Support which provides robust analytics for the center's various projects. This includes advanced air quality
monitoring and modeling, with integration of ML to enhance forecasting accuracy. Overall impact: The DSC’s
proposed infrastructure is poised to set a precedent whereby it serves as a national blueprint for climate policy
researchers. Adhering NIH data sharing principles, this infrastructure will act as a comprehensive repository for
diverse data on climate policy and health. The ultimate vision of DSC is to harness cutting-edge and equity-
centered data science tools and insights to guide the development of policies aimed at countering the adverse
effects of climate change on public health, benefiting not just the state of Wisconsin, but the nation and globe.

Public health relevance
PROJECT NARRATIVE Project Narra�ve is located in the Overall Component.